Molecular Correlates Of Human Ca2+ Channel Regulation

Section of Molecular and Clinical Pharmacology (Nikolai M. Soldatov, Ph.D.) The long-term objective of our research is to pursue the study of the structure-functional relationships of human cardiac and vascular L-type (Cav1.2) Ca2+ channels, and to investigate the molecular correlates for the channel regulation associated with alternative splicing, naturally occurring mutations, and voltage-gated conformational rearrangements. We hypothesize that Ca2+-induced inactivation of the a1C channel is mediated by the interaction of identified Ca2+ sensors (Soldatov et al., 1998) with site(s) associated with the pore. The Ca2+ sensors appear to be differently targeted by calmodulin and permeating Ca2+ (Romanin et al., 2000) and contribute to the voltage- and Ca2+-dependent inactivation of the channel. The Ca2+ sensor are also critical for the run-down (Kepplinger et al., 2000a) and effects of modulatory proteins such as auxiliary beta subunits (Soldatov et al., 1997; Kobrinsky et al., 2004), calmodulin (Romanin et al., 2000) and calpastatin (Kepplinger et al., 2000a). In addition, Ca2+ sensors were found to contribute to membrane targeting by a1C subunit and Ca2+ channels clusterization (Kepplinger et al., 2000b). Single-molecule fluorescence study confirmed large clusters of Cav1.2 channels (Harms et al., 2001). We extended our investigation of the molecular mechanisms of inactivation (Abernethy and Soldatov, 2002). Based on our data on human a1C,94 channel with inactivation impaired due to a naturally occurring mutation A752T at the cytoplasmic end of the transmembrane segment IIS6, we have identified a molecular determinant of slow voltage-dependent inactivation as a ring of hydrophobic residues in the inner pore region (Shi and Soldatov, 2002). Given the importance of the L-type Ca2+ channel in cardiovascular physiology, we plan to extend our investigation of the human a1C splice variants and pursue the following specific aims: (1) using fluorescence resonance energy transfer (FRET) as molecular ruler, to investigate the voltage-gated molecular rearrangements supporting inactivation of the Ca2+ channel and Ca2+ signal transduction mechanisms. (2) Cloning of the new human cardiac small beta2 subunits (Harry et al., 2004) opens new avenue for the identificatiion of the minimum essential determinant of Ca2+ channels modulation and its small biologically active homologues. (3) Using laser capture microdissection technique, RT-PCR and MS analysis, we will further investigate the diversity of a1C transcripts generated in human cardiac and vascular cells and tissues in response to age, drugs, hormonal and pathological stimuli. We will examine whether alterations in the molecular properties of the a1C channels occur with age and as a result of cardiovascular diseases, including atherosclerosis, hypertension, cardiomyopathy, ischemia, arrhythmias and heart failure. (4) The wavelet transform analysis will be developed and applied to investigate phosphorylation and otehr signaling microdomains associated with the activity of human L-type Ca2+ channels. The established links will be tested with transgenic animal models. Results of our study may give insights into the fundamental principles of Ca2+ signaling supporting transcription regulation as well as excitation-contraction coupling in human cardiac and vascular muscle cells and provide useful clues for molecular diagnostics and drug developments.